Regulation of alternative splicing during epithelial-mesenchymal transition

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest: Alzheimer’s-Focused
Administrative Supplements for NIH Grants that are Not Focused on Alzheimer’s Disease, with Notice Number:
NOT-AG-22-025. The overall goal for the funded parent award R35GM131876 is to investigate RNA binding
protein-mediated alternative splicing regulation during epithelial-mesenchymal transition.
Tauopathies are a diverse group of neurodegenerative diseases with varied presentations ranging from
progressive memory loss to parkinsonism. A common tauopathy is Alzheimer’s Disease (AD), which is the
primary cause of dementia worldwide. Tauopathies are characterized by the accumulation of intracellular
neurofibrillary tangles (NFTs) composed of aggregates of hyperphosphorylated Tau protein. To date, there exists
only one disease-modifying medication for AD treatment. The development of AD therapies that target Tau
pathology are still in a nascent stage. Increasing evidence has shown that AD is driven by local inflammation in
the brain. Recent findings implicated the type I interferon (IFN-I) response as a primary cause of
neuroinflammation and synapse loss in AD. The IFN-stimulated gene signature is significantly enriched in murine
AD models and correlated with clinical AD disease severity. Downregulating the neural IFN-I pathway restores
pre-synaptic terminals and decreases plaque accumulation. Therefore, IFN-I constitutes a pivotal element within
the neuroinflammatory network of AD and critically contributes to neuropathogenic processes. However, the
mechanisms that stimulate neural IFN-I response remain elusive. Our lab recently discovered that hnRNPM, a
ubiquitously expressed RNA binding protein (RBP), is critical for maintaining transcriptome integrity. We found
that loss of hnRNPM promotes cryptic splicing. These cryptically spliced products further stimulate the IFN-I
response. Interestingly, AD patient brains express decreased levels of hnRNPM. These results lead us to
hypothesize that hnRNPM loss promotes AD through induction of cryptic splicing-mediated IFN-I
response. We have designed two Specific Aims to test this hypothesis. In Aim 1, we will use iPSC-derived
neurons from normal and tauopathy patients and examine whether hnRNPM loss stimulates IFN-I response due
to cryptic splicing. In Aim 2, we will use patient iPSC-derived neurons and other established in vitro systems to
determine whether loss of hnRNPM accelerates tauopathy-associated molecular phenotypes, including
accumulation of Tau hyperphosphorylation and aggregation, and NFTs. Successful completion of these aims
will help elucidate a novel mechanism of IFN-I activation in Tauopathy neurons governed by RNA dysregulation.

Public health relevance
PROJECT NARRATIVE Type-I interferon (IFN-I) response escalates the pathological phenotypes of neurons in Alzheimer's disease. But the mechanisms that activate IFN-I in neurons remain poorly understood. This project will test whether cryptic splicing in neurons induces IFN-I response, contributing to the progression of Alzheimer's disease.